Predicting TCR and BCR specificity to microbiomes by massively mining RNA-seq samples

T cells and B cells play important roles in our immune system by recognizing various antigens, including
bacteria and viruses, through their diverse receptors T-cell receptors and B-cell receptors (TCRs and
BCRs). The total set of TCRs and BCRs in a person is called immune repertoire, and analyzing immune
repertoire can reveal valuable health information and guide treatment strategies. One of the key steps for
understanding immune repertoire is to identify the binding target of each TCR and BCR. Researchers have
developed experimental techniques to capture the receptors recognizing the input antigens. However, the
profiled antigens on these platforms are very scarce, even when compared with the microbiome species
with known genome sequences. Thanks to the development of sequencing technology, we can investigate
the genomic or RNA information at bulk or single-cell level for a large number of samples. In a series of our
previous works, we demonstrated the ability to extract micro
biome information and immune repertoire information from sequencing data. With these methods, each
sample can give a glimpse of the immune repertoire and microbiome interactions, suggesting that we may
associate the TCRs and BCRs with their binding targets by inspecting sufficient samples. In order to
efficiently process huge amounts of raw sequencing data sets, we will develop novel computational
methods that can remarkably reduce the computational overhead. Additionally, we will extend these
methods to work on a broader scope of sequencing platforms to incorporate more samples in this study.
After obtaining the immune repertoire and microbiome data across the samples, we will curate the
resources into a database and develop computational and statistical tools to annotate the user-input TCRs
and BCRs with their microbiome binding targets.